Fibroblast Growth Factor 23 (FGF23) and It's Receptors

DESCRIPTION (provided by applicant): This NIH mentored Career Development Award proposal describes a five year training program for the development of an academic career of a physician scientist and to facilitate the transition to an independent investigator. To accomplish these goals, the candidate and her mentors have developed an integrated plan including innovative scientific ideas, advanced training in the field of basic science research and a detailed career development plan. This research will focus on elucidating FGF23 causes decreased phosphate reabsorption from the kidney by decreasing the expression of phosphate transporter in the proximal tubule. In addition, FGF23 decreases synthesis of 1,25 vitamin D in the proximal tubule. The receptors responsible for these different actions of FGF23 are unknown. It is known that the FGF family members bind to four fibroblast growth factor receptors (FGFRs) designated as FGFR1-4. FGFR1, FGFR3 and FGFR4 are present in the proximal tubule where the majority of phosphorus is reabsorbed. A recent in vivo study using FGFR null mice indicates that FGFR1 is the predominant receptor with FGFR4 playing a minor role in regulating the phosphate transporters in the proximal tubule, but baseline phosphate homeostasis remains normal in these FGFR null mice. This grant proposes that compensatory mechanisms exist at baseline in individual FGFR-/- mice and FGFR1-/-FGFR4-/- double mutant mice will have high serum phosphate levels at baseline and have resistance to FGF23. To test this hypothesis, FGFR1-/-FGFR4-/- mice will be generated and characterized, and the effects of FGF23 will be examined. Regulation of 1,25 vitamin D appears to be different from the regulation of sodium phosphate cotransporters with individual FGFR null mice showing significant decrease in the serum levels of 1,25 vitamin D on exposure to pharmacological doses of FGF23. To study the regulation of 1,25 vitamin D, different combinations of FGFR null mice will be examined for the effects of FGF23 on serum levels of 1,25 vitamin D. This grant also hypothesizes that Klotho, an essential co-factor for the actions of FGF23 can act as an independent phosphate regulating hormone, and it interacts with FGFRs to regulate phosphate homeostasis. To test this hypothesis, the effects of Klotho on phosphate homoeostasis will be studied in the various FGFR null mice. In humans, high FGF23 levels result in disturbances in phosphate homeostasis with hypophosphatemia and low 1,25 Vitamin D levels resulting in rickets, bone fractures and poor growth. High levels of FGF23 have also been associated with increased risk of mortality in patients with chronic kidney disease. Identifying the receptors for FGF23 will provide insights in to the mechanisms of actions of FGF23 and provide foundation for designing novel therapies to prevent the effects of FGF23.

Public health relevance
PUBLIC HEALTH RELEVANCE: Patients with high levels of FGF23 have rickets, poor growth, and increased risk of fractures, and lack curative therapy. The current therapy results in kidney stones and progressive renal injury. The identification of specific receptors for FGF23 will help in designing specific receptor antagonists and thus provide curative treatment. Project Narrative: Patients with high levels of FGF23 have rickets, poor growth, and increased risk of fractures, and lack curative therapy. The current therapy results in kidney stones and progressive renal injury. The identification of specific receptors for FGF23 will help in designing specific receptor antagonists and thus provide curative treatment. __SpecificAimsTextDelimiter__ A. SPECIFIC AIMS Fibroblast growth factor 23 (FGF23) is a phosphate regulating hormone that increases phosphate excretion by reducing the expression of sodium phosphate co-transporters (NaPi-2a and NaPi-2c) on the proximal tubule and decreases serum levels of 1,25(OH)2Vitamin D3. X-linked hypophosphatemic rickets (XLH), autosomal recessive hypophosphatemic rickets (ARHR), and autosomal dominant hypophosphatemic rickets (ADHR) are some of the hypophosphatemic disorders resulting from dysregulation of FGF23. The specific receptor(s) for the different actions of FGF23 remain unknown. It is well known that the fibroblast growth factor family members bind to fibroblast growth factor receptors (FGFRs) to initiate intracellular signaling. Four FGFRs coded by four genes have been identified and designated as FGFR1-4. Splice variants exist for FGFR1-3 and this provides distinct ligand specificity. FGF23 requires Klotho as a co-receptor, which simultaneously interacts with FGF23 and FGFR(s) to stabilize FGF23-FGFR binding. We hypothesize that different FGF receptors regulate different functions of FGF23. To test this hypothesis, we have proposed the following specific aims which will help in identifying the specific FGF receptors for the different actions of FGF23. Aim 1. To determine the FGF receptors responsible for regulating phosphate transport in the kidney by FGF23. The specific receptors for the hypophosphatemic actions of FGF23 remain elusive. Controversy exists regarding the specific receptor for FGF23 using in vitro techniques. An in vivo study showed that the hypophosphatemic phenotype of Hyp mouse (mouse model of X-linked hypophosphatemic rickets) was not affected when cross-bred with either FGFR3-/- or FGFR4-/- mice. Moreover, we have recently shown that upon administration of pharmacological doses of FGF23 to the different FGF receptor null mice, FGFR1 is the predominant receptor for the hypophosphatemic actions of FGF23 with FGFR4 likely playing a minor role. However, at baseline these FGFR null mice have normal serum phosphorus levels. Thus, it appears that FGF23 signals through more than FGFR1 and deletion of one receptor may be compensated by other receptor(s). To study this further, we will characterize phosphate homeostasis in FGFR1-/-/FGFR4-/- double mutant mice at baseline and after FGF23 administration. Aim 2. To examine which receptor(s) are responsible for the regulation of 1,25(OH)2Vitamin D3 by FGF23. 1,25(OH)2Vitamin D3 is primarily synthesized in the proximal tubule by 25-hydroxvitamin D-1α- hydroxylase enzyme (1α-hydroxylase). FGF23 decreases expression of 1α-hydroxylase and increases expression of 25-hydroxvitamin D-24-hydroxylase enzyme (24 hydroxylase), which degrades 1,25(OH)2Vitamin D3 thus decreasing serum levels of 1,25(OH)2Vitamin D3. We have shown that upon administration of FGF23, serum 1,25(OH)2Vitamin D3 levels decrease in all the individual FGFR-/- mice and wild type mice. This indicates that the regulation of 1,25(OH)2Vitamin D3 is different from that of regulation of sodium phosphate co- transporter expression even though synthesis and degradation of 1,25(OH)2Vitamin D3 primarily occurs in the proximal tubule and sodium phosphate co-transporters are expressed on the brush border of the proximal tubule. In our preliminary data, we also show that 1,25(OH)2Vitamin D3 levels do no change in response to FGF23 in FGFR3-/-/FGFR4-/- double mutant mice. We will further characterize the FGFR3-/-/FGFR4-/- double mutant mice to better understand the regulation of 1,25(OH)2Vitamin D3 by FGF23. Aim 3. To determine if Klotho regulates phosphate homeostasis through FGF receptors. Klotho, a single transmembrane protein involved in aging has been shown to interact with FGF23 and FGFRs simultaneously and increase the affinity of FGF23 to its receptors. Our preliminary data suggest that Klotho by itself can cause a decrease in phosphate transport in isolated proximal tubules as seen in transgenic mice over expressing Klotho. Moreover, incubation of isolated proximal tubules with Klotho, either in the lumen or in the bath decreases NaPi-2a expression. It is yet unknown if Klotho interacts with its own receptors that have not yet been identified or Klotho primarily interacts with FGFRs to initiate intracellular signaling. We will examine the effects of Klotho in the different FGFR-/- mice in order to identify if Klotho's hypophosphatemic action is dependent on FGFRs.